Pathways to Cancer Research Renewal

ABSTRACT
Pathways to Cancer Research Renewal (“Pathways Renewal”) is a renewal of the Pathways
to Cancer Research grant R25 CA221770 awarded to Fred Hutchinson Cancer Research
Center (“Fred Hutch”) in Seattle, Washington. It is designed to meet the goals of the National
Institutes of Health (NIH) and National Cancer Institute (NCI) to broaden participation of
underrepresented populations in science and thereby increase the diversity of the scientific
workforce. This renewal places a strong emphasis on developing two major focus areas across
our Pathways programs - computational biology and cancer health inequities. These areas
of importance were identified by our students and are also priorities of NCI/NIH. We will build on
the prior investments NCI has made in our science education efforts through the YES R25
mechanism, introducing new and innovative components and strengthening our existing
Pathways programs for educators and underrepresented high school and undergraduate
students. We will develop and offer two new virtual high school activities that were piloted in
2021 in response to the pandemic: an outreach program that focuses on using computational
tools to analyze cancer datasets, and a school-year academic research internship. Our aims for
this proposal are to: 1) Provide “Hutch Teacher Fellowship” mentored multi-year research
experiences for secondary science teachers, preparing them to develop curriculum materials
focused on computational biology and cancer health inequities; 2) Expand our “Explorers” and
“Coding for Cancer” introductory outreach programs aimed at increasing the pool of eligible
youth interested in cancer research in general, and computational biology and cancer health
inequities in particular; and 3) Thread opportunities for computational analysis and community
action related to cancer health inequities throughout our “Explorers Virtual School-Year
Internship” and “Pathways Undergraduate Researchers” mentored, multi-year research
internship experiences. Across our programs, we place a strong emphasis on the development
of scientific identity, fostering a sense of belonging in science, and preparing students to
communicate science to their families and communities. Our integrated and holistic approach
builds on the long-standing, robust institutional support for science education at Fred Hutch, our
successful history of engaging and supporting underrepresented students to pursue cancer
research careers, and the strength of our science education staff and scientific faculty.

Public health relevance
NARRATIVE Pathways to Cancer Research Renewal attracts underrepresented and economically disadvantaged students to science, inspires them to pursue research careers, and supports them as they advance professionally. Increasing diversity among researchers brings new perspectives that stimulate innovation and that ensures future cancer researchers will represent the communities they serve, including populations disproportionately impacted by cancer. This renewal has a special emphasis on two areas of need identified by the NCI: the role of computational biology in current and future research and the importance of working with communities to address health inequities.